Remodeling of the host epigenome during EBV infection

Project Summary
In EBV+ lymphomas viral protein expression is the oncogenic driver and progressive force. However, the
mechanisms by which EBV infection alters B cell biology to contribute to the development of EBV+ lymphomas
are not well understood. EBV infection of primary B lymphocytes results in cell activation, proliferation, and
immortalization. These programs are induced by EBV mimicking the normal activation of B cells by antigens or
T cells. Since LMP1 is needed for EBV to transform naïve B cells into immortalized B cells, considerable work
has been attempted to pharmacologically target the LMP1-activated oncogenic pathways. However, in vivo
attempts to target these pathways have failed to abolish EBV-driven oncogenesis completely. This lack of
efficacy of the targeted approaches suggested to us that another, undiscovered or unappreciated, oncogenic
mechanism downstream of LMP1 might be at work. This proposal aims to identify the mechanism by which EBV
infection contributes to developing B cell malignancies.
Our recent, published work showed that the EBV oncoprotein LMP1 activates the chromatin-associated factor
PARP1 to epigenetically regulate genes that are important for sustaining cell proliferation. Expanding upon these
findings, our preliminary data indicate that the reorganization of the 3D structure and function of chromatin in B
cells is a novel and underappreciated mechanism targeted by EBV through LMP1 to alter gene expression and
reprogramming in EBV infected cells. We discovered that: 1) expression of LMP1 alone is sufficient to alter the
3D structure of the B cell genome; 2) the EBV/LMP1-induced changes in chromatin structure are associated with
PARP1 activity, and with occupancy by the chromatin organizers CTCF and YY1; 3) EBV activation of PARP1
requires ERK activation by LMP1; and 4) PARP inhibitors elicit cytotoxicity in EBV+ lymphomas in vivo. Based
on these preliminary data and our previous work we hypothesize that in EBV+ B cells, LMP1 expression
activates, via the ERK pathway, PARP1, promoting conformational changes in the host genome architecture that
drive oncogenesis. We will also test the hypothesis that PARP1 is an attractive therapeutic target for EBV
lymphomas.

Public health relevance
Project Narrative EBV infection usually has a benign outcome, yet 1.5% of all cancer worldwide are associated with EBV infection, including Non-Hodgkin’s Lymphoma (NHL) and Hodgkin’s disease (HD). This proposal will reveal new mechanisms regulating host-virus interactions that contribute to EBV lymphomagenesis.